Neuronal and Bacterial Driven Inflammation of the Dental Pulp in Molar Hypomineralization

Project Summary
Molar hypomineralization (MH) is a prevalent enamel defect affecting 15% of children worldwide and is
characterized by soft and porous demarcated opacities on the enamel surfaces of primary and permanent
dentition. These soft spots on enamel have elevated protein content, hindering restorative success. This
defective enamel's unique structure and composition facilitate the continuous transmission of oral stimuli to the
dentin-pulp complex underneath the enamel. Therefore, children with MH suffer greatly from longstanding
hypersensitivity associated with an underlying pulpal inflammation called pulpitis. However, the mechanisms of
bacterial-induced pulpitis fail to explain the MH-associated pulpitis, hindering effective diagnosis and treatment.
This project aims to dissect the role of sensory neuron-driven and bacterial-driven activation of pulpitis in MH
using in vivo and ex vivo approaches by studying the innate immune responses of the dentin-pulp complex.
Finally, we aim to test the effect of enamel remineralization on bacterial colonization and bacterial-driven immune
response of the dental pulp organ. We hypothesize that continuous activation of the sensory neurons and
bacterial infection contribute to the development of pulpitis in MH in tandem, and treatment of the soft enamel
will reduce the pulpal response. Two specific aims are proposed to test this hypothesis: Aim1) The role of sensory
neuron activation in pulpal inflammation will be examined using a hypomineralized KLK4-KO mouse model and
WT mice. Sensory afferents will be activated with repetitive noxious stimuli, and the innate immune responses
in dental pulp tissue will be assessed by flow cytometry, cytokine analysis, and immunofluorescence imaging.
Aim 2.1) The role of bacterial infection in MH-associated pulpal inflammation will be investigated by quantifying
bacterial colonization and activity on enamel surfaces and assessing the therapeutic impact of silver diamine
fluoride. Aim 2.2) The bacteria-induced pulpal immune response will be assessed. Topical SDF application will
aim to remineralize the soft enamel, reduce bacterial colonization on the surface, and improve the barrier function
of enamel against bacterial infection, ultimately reducing inflammatory responses. This research project will shed
light on the mechanistic components of pulpitis in MH patients and facilitate the researcher's transition towards
an independent clinician-scientist career track. During this 5-year K08 Mentored Career Development Award
(PA-20-203), Dr. Karaaslan will receive training and test the proposed two aims under a multidisciplinary team
of mentors and experts in hard tissue biology, microbiology, immunology, and pulp biology. Ultimately, the results
of this study will guide translational and clinical studies to develop targeted therapeutics to prevent and treat
pulpitis in MH patients and the general population.

Public health relevance
PROJECT NARRATIVE Molar Hypomineralization (MH) is a prevalent enamel defect affecting 15% of children worldwide; it manifests on the enamel surface as soft and porous demarcated opacities with reduced restorative success and is highly associated with hypersensitivity caused by pulpal inflammation. This project aims to investigate the unknown mechanisms underlying pulpitis development in MH by studying the effects of repetitive noxious stimulus and bacterial infection on dental pulp inflammation in hypomineralized teeth and the effect of enamel remineralization to prevent bacterial infection. The results of this project will shed light on the pathomechanisms of pulpitis in MH to facilitate targeted diagnosis and improved treatment plans, ultimately reducing the global burden of pulpitis in MH and the general population.